96 HR INFUSION OF ICRF 187 FOLLOWED BY 72 HR INFUSION OF TOPOTECAN

Objectives of the study are to establish the mtd of a 96-hour continuous infusion of fixed dose icrf-187 followed by dose-escalated topotecan given as a 72 hour continuous infusion; and to determine the pharmacokinetics of icrf-187 and its active metabolite icrf-198 and topotecan in plasma when administered on this schedule. treatment cycles will be repeated every 28 days.